QUANTUM DOT LABELING OF SPERM TAILS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Quantum dot labeling on CatSper on sperm tail. Assistance with labeling protocols desired.